The regulation of early life interleukin-27 expression and metabolic impact

PROJECT SUMMARY Microbial infections are a major cause of infant mortality worldwide. For particularly vulnerable populations such as pre-term and low birth weight babies, the risk of invasive infections further escalates. The neonatal period is defined by a distinct or immature immune system, and many features of a protective host response to infection are deficient as compared with older children and adults. Our laboratory has identified that expression of the immune suppressive cytokine interleukin (IL)-27 is elevated in human and murine neonates. Other recent studies have shown IL-27 to be a biomarker for early onset neonatal sepsis. This suggests that elevated IL-27 may represent a risk factor and when further increased during bacterial challenge, compromise the host immune response. We have shown that macrophages and myeloid-derived suppressor cells (MDSCs) are the dominant sources of elevated IL-27 in the neonatal phase and their contributions manifest as elevated levels of serum IL-27 compared with older populations. Cumulatively, this points to IL-27 as a host molecule that represents a target for immune intervention to improve the host response and reduce susceptibility to infection early in life. We present strong evidence in a mouse model that the absence of IL-27 signaling translates to improved survival, better weight gain, and enhanced clearance of bacteria during neonatal sepsis. In the current proposal, we seek to understand the regulation of elevated levels of early life IL-27 and the functional consequence to neonates during infection. A deeper understanding of these aspects of IL-27 biology will help to inform targeted approaches to mitigate IL-27-regulated deficiencies in the host response to infection. In the first aim we explore the hypothesis that IL-27 genes are hypomethylated in neonates allowing for increased expression that is reduced in adults by methylation. In the second aim we investigate the hypothesis that IL-27 contributes to the regulation of glucose homeostasis. This hypothesis is derived from the observation in our murine sepsis model, that IL-27 receptor-deficient neonates resist hypoglycemia that develops during neonatal sepsis. The transcriptome will be examined in tissues from wild-type and IL-27 receptor-deficient neonatal pups in the presence and absence of infection. At the completion of this project, we expect to have an enhanced understanding of regulatory mechanisms that contribute to differential IL-27 expression early in life and uncovered a novel link between host immunity and glucose homeostasis. These findings will have translational value and the potential to improve outcomes in human neonates.

Public health relevance
PROJECT NARRATIVE Neonates exhibit increased susceptibility to microbial infections that include bacterial sepsis. This is reflective of a distinct immune profile relative to adults that is often referred to as immature. The research described in this proposal will make important advances toward identification of mechanisms that shape an altered immunologic profile and the functional consequences in neonates.